Improving Preclinical Translation in Alzheimer's Disease Research

PROJECT SUMMARY/ABSTRACT
Our long-term goal is to ensure that rigorous, best-practice scientific methods are consistently applied in
experiments generating preclinical data for potential therapies for Alzheimer’s disease (AD). The number of AD
cases is rising dramatically worldwide, and there is an urgent need to develop effective new therapies beyond
the modest efficacy of the current FDA approved drugs for AD. Given that data from preclinical drug screening
in animal models are used to inform clinical trials in AD patients, it is critical to ensure the highest level of rigor
and assurances for successful translation from animal models to human patients. Unfortunately, in preclinical
drug testing studies, there has been evidence of deficiencies in experimental design, sample size, data analysis,
optimization of drug screening pipelines, and experience of individuals generating the data, together indicating
a need for better training in preclinical drug discovery and translational medicine methodologies and processes.
Over the last three years we have successfully delivered an annual course that meets this need by providing the
necessary hands-on as well as theoretical training in fundamental skillsets required for conducting rigorous in
vivo studies in AD mouse models. Herein we propose to continue providing this nationally available, immersion
workshop focused on Principles and Techniques for Improving Preclinical Translation of Alzheimer’s Disease
Research, to be held at The Jackson Laboratory (JAX) in Bar Harbor, ME that will leverage the expertise of the
Indiana University (IU)/JAX/University of Pittsburgh (PITT) Model Organism Development for Evaluation of Late
Onset Alzheimer’s Disease (MODEL-AD) consortium. This training collaboration will convene experts with
diverse complementary skills ranging from mouse genetics to statistics to preclinical testing at a state-of-the-art
residential conference center and hands-on training facility for mice at JAX. The workshop will ensure a diverse
group across professional levels and have appropriate representation of traditionally underrepresented
individuals as workshop participants, and supported by scholarships. In line with the NIH initiative on rigor and
reproducibility, the workshop aims to address training gaps in preclinical drug screening by providing participants
with the skills and knowledge required for rigorous design, execution, analysis, and reporting of pharmacokinetic,
pharmacodynamics, and preclinical efficacy experiments. The workshop is innovative in that it includes a
significant amount of hands-on, practical laboratory training in in vivo drug screening methodologies. The specific
aims of the workshop are to 1) Train participants in the rigorous design, experimental execution, analysis, and
reporting of data in line with the ARRIVE guidelines for preclinical testing of AD therapies. 2) Provide participants
with the practical laboratory tools and skills to perform rigorous, reproducible preclinical tests on mouse models
of AD. 3) Promote interaction and discussion between faculty and students to foster open, honest dialogue and
collaborative research across a diversity of participant backgrounds. Our innovative and comprehensive
workshop will offer a critical, unique hands-on training experience that is possible only at JAX.

Public health relevance
NARRATIVE Given the increasing health and economic burdens associated with the burgeoning number of Alzheimer’s disease (AD) cases throughout the world, there is an urgent need to develop therapeutic agents that can treat, delay, or prevent the disease. However, development of effective new therapies has been hindered by a lack of the skills and knowledge required to perform scientifically rigorous preclinical drug-screening studies, which are typically carried out using laboratory mice. This proposal aims to address these gaps by developing and delivering a workshop at The Jackson Laboratory, a world-renowned center of expertise in the analysis of mouse models, that will provide participants with hands-on training and lecture instruction that will enable the rigorous design, execution, analysis, and reporting of preclinical experiments that will have potential to bring new AD therapies to the clinic.